Clinician-Scientist Research Incubator for Practice-based Training (Clin.ScRIPT)

Project Abstract
Training in Clinical Dental Research is fundamental to the progress of the profession and patient care. Current
opportunities in US dental schools are limited. Our proposal will recruit and train the next generation of Dental
Clinician-Scientists. Our project will create a new 2-year MS in Clinical Dental Research, a Clinical Research
Network, a Clinical Research Mentorship Pathway, a regional clinical research symposium, and a
developmental, multi-site clinical study quantifying the effects of inflammation levels on dental implant
success.
Our tactic is: Formal and informal training and skills development in clinical dental research, collaborative
arrangements with various institutions, facilitation of mentorship relationships, and a development multi-site
clinical study.
Our overall objective is: to make a substantial impact on the future of clinical dental research through training,
collaboration, and mentorship of the clinician-scientists of the future.
Our specific aims are: 1: To increase formal clinical research training opportunities, we will develop a new MS
program in Clinical Dental Research. This program will produce the next generation of dental clinician-scientists
who understand research, are well equipped to contribute, and who actively advance patient outcomes through
enhanced implementation of evidence-based care. 2: To expand our research network and capabilities, we will
collaborate with multiple partners from other institutions and Augusta University (AU) Colleges. 3: To promote
mentoring, we will build a clinical dental research network and resource center consisting of a clinical research
mentorship pathway, increased engagement with the DCG student dental research society and DCG FOSTER
program, and a repository of available funding, training, and support opportunities available to new clinical
investigators. 4: To demonstrate the applicability of practice-based clinical research, we will perform the following
developmental, multi-center, 3-year investigation: “Salivary inflammatory marker levels predictive ability for
quantified marginal bone loss (MBL) around dental implants and risk of implant failure.” The primary outcome of
this study is quantification of the prognostic ability of inflammatory markers in saliva for marginal bone loss
around dental implants.
Future goals include: 1) collaborative clinical research training opportunities for students, residents, and faculty
from other dental colleges, and 2) a robust, largely asynchronous, clinical research certificate training program
available remotely.

Public health relevance
Project Narrative Training and skills development in clinical dental research are imperative to continued improvements in the quality of oral health care in the US, yet dental schools, residency programs, and clinical faculty are generally lacking in this area. Our proposal aims to improve the current state of such training through development of a 2- year MS in Clinical Dental Research, a Clinical Research Resource Network and Resource Center, a Mentorship Pathway, a regional clinical research symposium, and a multi-site developmental clinical study seeking to improve treatment for dental implant patients. Our multidisciplinary, practice-based research incubator is relevant to the NIDCR’s mission in that it will create the next generation of dental clinician-scientists who will create, improve, and deliver evidence-based care for our patients.